NRG Oncology Network Group Operations Center

NRG Oncology
Operational Ontology for Oncology (O3) towards AI/ML Ready Standardization
Charles Mayo, PhD, Supplement Principal Investigator
Project Summary
The parent grant, NRG Oncology, was formed as a collaborative effort between the former National Surgical
Adjuvant Breast and Bowel Project (NSABP), the Radiation Therapy Oncology Group (RTOG), and the
Gynecologic Oncology Group (GOG) with the goal of improving the lives of cancer patients through practice-
changing multi-institutional clinical and translational research, with emphases on gender-specific malignancies
and localized or locally advanced cancers of all types. This proposal outlines a supplement project that aims to
develop user-friendly tools to enable the seamless conversion between different data standards for radiotherapy
data elements collected during NCI clinical trials. The project targets the standardization and interoperability of
radiotherapy data, which is crucial for facilitating the use of machine learning and artificial intelligence in the field.
The project's specific aims include developing a comprehensive mapping and conversion framework between
OOO/FHIR, CDISC, OMOP, and NCI Thesaurus standards, designing and implementing user-friendly tools for
data aggregation and seamless conversion, and pilot testing and validating the developed tools with collaborating
institutions and NCI clinical trial data. The team will coordinate with leadership from these standards groups to
ensure accuracy in mapping and concept definitions. The tools developed will incorporate data validation and
error-handling mechanisms to ensure data quality and integrity during the conversion process. Ultimately, the
project aims to promote the adoption of these tools by the broader radiation oncology community, specifically for
NCI clinical trials, and contribute to improving cancer patient outcomes and advancing cancer research.
The aims of the project are:
Aim 1 - We will extend our prior work with O3, providing easily accessible, publicly available mappings
between O3, OMOP, CDISC, NCI Thesaurus and HL7-FHIR supporting clinical trials for cancer care.
Aim 2 – We will extend our tools for data extraction supporting mapping and connection of O3 based
Artificial Intelligence (AI) ready data sets to machine learning algorithms.
Aim 3 The tools developed in aim 2 will be used by a set of institutions to demonstrate the ability to
aggregate RTOG 0617 information for a representative (5 patients/institution) set of patients.
Aim 4 Mappings and tools will be published on a publicly accessible GitHub repository.

Public health relevance
NRG Oncology Operational Ontology for Oncology (O3) towards AI/ML Ready Standardization Charles Mayo, PhD, Supplement Principal Investigator Project Narrative This proposal outlines a project that seeks to create user-friendly tools to convert cancer patient data collected during clinical trials into a standardized format. These tools can facilitate the use of machine learning and artificial intelligence to analyze the data and uncover new cancer treatments. The project aims to test and share the tools with other researchers in the radiation oncology community to enable wider adoption of the tools and to enhance cancer research outcomes.